Novel Statistical Methods for Oral Microbiome Data Analysis

PROJECT SUMMARY
The oral cavity harbors a great diversity of microbiota that play an important role in human health. Studies have
shown that alterations in the oral microbiome are closely associated with oral diseases such as periodontitis and
dental caries, as well as numerous extra-oral disorders such as diabetes and cardiovascular diseases. Large-
scale epidemiological studies, including our motivating Oral Infections, Glucose Intolerance and Insulin
Resistance Study (ORIGINS), have collected rich data to further investigate the association and mechanistic
pathways between the oral microbial communities and health outcomes. However, microbiome data are
complex, subject to constraints such as compositionality, zero inflation, overdispersion, taxonomic hierarchy,
and high dimensionality. Most existing statistical analyses rely on ad hoc data manipulation and transformation
approaches to bypass these constraints, often leading to uninterpretable and irreproducible results. There is a
pressing need for more principled statistical methods. This proposal will develop novel association and mediation
methods that fully accommodate the unique data features and harness the power of microbiome data. We will
build upon a nascent relative-shift regression framework that provides a highly intuitive and interpretable way of
modeling compositional data. In Aim 1, we will significantly extend the scope of the relative-shift model by
generalizing it to non-Gaussian responses and nolinear relationships. The new methods can better depict the
complex association between microbiota and diverse phenotypes. In Aim 2, we will develop novel mediation
methods with microbial exposures (Sub-Aim 2a) and microbial mediators (Sub-Aim 2b). The methods will provide
a solid foundation for quantifying and testing mediation effects pertaining to microbiome data. The proposed
methods will be applied to the ORIGINS data to identify crucial oral microbiota associated with oral/extra-oral
phenotypes and to delineate the mediation pathways. The methods and an accompanying software package will
also have general utilities in other microbiome studies and promise to enhance our understanding of the
microbiome’s critical role in human health.

Public health relevance
PROJECT NARRATIVE The oral cavity is home to diverse microbiota that play a critical role in human health. By developing statistically sound association and causal mediation methods for microbiome data analysis, the project will enhance our understanding of the relationship between oral microbiota and human health and provide potential targets for new therapies.